Clinical Research on AIDS Training Grant

[unreadable] DESCRIPTION (provided by applicant): The University of Washington, Department of Biostatistics, together with faculty from the Departments of Epidemiology, Medicine and Statistics, proposes to train biostatisticians for collaborative work in HIV/AIDS research. This renewal of a very successful training grant would support 4 predoctoral trainees. The PhD program includes coursework in statistical theory, biostatistical methodology, and data analysis, and a statistical consulting practicum. Coursework in the biological sciences related to HIV/AIDS, and an oral examination on a topic in HIV/AIDS biology or medicine, are required. After satisfying these requirements the student proceeds to complete a doctoral dissertation. The research component of the training program will focus on collaboration in ongoing biostatistical methodology research and significant involvement in HIV/AIDS clinical research projects. All trainees are additionally required to attend and contribute to ongoing seminar series that provide collaborative HIV/AIDS research opportunities. Students are enrolled with prior training in mathematics, statistics, or the biological sciences. Program prerequisites include linear algebra, probability, and two years of calculus; promising students with biology majors may be admitted provisionally if they have not satisfied all the mathematical prerequisites. [unreadable] [unreadable] [unreadable]